TRAINING IN NEONATAL AND DEVELOPMENTAL DISEASES

DESCRIPTION (provided by applicant): This is a new training program in Neonatal and Developmental Diseases which will be established within UCLA School of Medicine's existing Neonatology Program. This is a five year program geared towards training postresident neonatology fellows (M.D. and M.D., Ph.D.) with the idea of developing independent and productive physician- scientists and training of postdoctoral Ph.D. fellows in the area of neonatal and developmental diseases. This program will strive to attract individuals with a commitment towards academic medicine, provide a scientifically rich environment where M.D. and Ph.D. postresident and postdoctoral trainees will be afforded the opportunity of training side-by-side in established laboratories with expertise in developmental biology, genetics, molecular biology, and cell biology. Program faculty have been chosen from diverse fields and from various departments at the UCLA School of Medicine, with a Nationally reputable research program and a proven track record in training scientists and clinicians. The program is structured to include clinical neonatology training (as per the requirements spelled out by the American Board of Pediatrics) a bulk of which will occur during the first year, the second and third years will be devoted to training in laboratory-based research for the postresidency fellows. Following this initial training period, and after rigorous evaluation, the postresidency fellows will be allowed to progress into the postdoctoral portion of their fellowship that will consist of two additional years (four and five) following which they will be expected to obtain independent funding for their research programs. This training program requests support from NICHD for only years two, three and four. In addition, postdoctoral Ph.D. fellows will be afforded a three year training period, of which this program requests funds for only the first year, with the expectation that they will obtain independent postdoctoral fellowship support from independent applications for support. Given the available faculty mentors, the facilities, the structure, a formal evaluation process, and the expectations both at recruitment and throughout the training period, this training program is expected to produce independent investigators in the field of Neonatal and Developmental Diseases.